Quantitative Single-Cell Assessment of Lentivirus Susceptibility Determinants

Following our initial publication in which we identified that cholesterol levels induced by glycolytic activity are critical for efficient HIV-1 fusion with humans cells (Coomer et al., PLoS Pathog. 16: e1008359, 2020), we are employing some of the same experimental methods to better understand the impact that host cell lipids and host antiviral proteins have on HIV fusion with target cells. Specifically, we are addressing how HIV virion content affects the function of HIV Envelope, the viral fusion protein responsible for gaining entry into cells. We aim to understand how the conformational dynamics and clustering of Envelope are impacted by interferon and interferon-stimulated genes that regulate membrane fluidity of the HIV virion. This work is in progress and ongoing.